UCLA Rapid, Relevant, Rigorous Implementation Science Hub

PROJECT SUMMARY
Implementation science (IS) plays an increasingly important role in the advancement of HIV research.
Inherently multidisciplinary, IS recognizes that healthcare systems and communities often struggle to provide
high quality services with limited resources. IS offers a growing number of evidence-based strategies for
incorporating research investments in order to improve healthcare value and public health. Moving substantial
investments in HIV research into practice in rapid, rigorous, and relevant ways is critical. The UCLA Rapid,
Rigorous, Relevant Implementation Science Hub (UCLA 3R Hub) will provide IS expertise and, in coordination
with the other Hubs, meet the demand for effective and efficient ways to translate HIV research into practice.
The unique goal of the Hub is to provide leadership and support for rapid, rigorous, and relevant (3R) HIV-
related implementation research emphasizing pragmatic study designs and methods that address health equity
and produce sustainable solutions. We will reach this goal by accomplishing the following Specific Aims: 1)
Build IS knowledge and capacity among EHE grantees by providing technical assistance (TA), coaching, and
consultation to EHE grantees; 2) Collaborate with the Coordination, Consultation, and Data Management
Center (CCDMC) and Regional Consultation Hubs (RCHs) by identifying resources and opportunities for
advancing evidence-based interventions through the implementation pipeline; and 3) Build IS capacity in the
HIV research community by providing and continuously enhancing, expanding, and refining a platform for
learning in support of HIV-related implementation research, primarily through virtual IS Beachside Chats and IS
Methods Workshops. EHE awardees assigned to the UCLA 3R Hub will have access to individualized TA,
consultation, and coaching sessions; all-awardee meetings; IS Methods Workshops; IS Beachside Chats; and
lectures and resources that will advance the application of IS concepts, theories, frameworks, and methods.
Additionally, the UCLA 3R Hub will support the Coordinating Center’s efforts to advance shared measures and
frameworks across the projects and via collective, synergistic activities. The UCLA 3R Hub team has a strong
history of and urgent commitment to centering a health equity lens and engaging and mentoring diverse
investigators, including racial/ethnic and sexual/gender minorities. Collectively, these activities and efforts will
promote the research priorities of the EHE initiative, thereby enhancing HIV research and its impacts and
applications in clinical care and public health more broadly.

Public health relevance
PROJECT NARRATIVE Healthcare systems often struggle to provide more services with fewer resources. Implementation science offers evidence-based strategies for incorporating research investments to enhance value and improve public health. The UCLA Rapid, Rigorous, Relevant Implementation Science Hub (UCLA 3R Hub) will provide leadership and support for rapid, rigorous, and relevant implementation research through innovative activities that will expand and promote the research priorities of the EHE initiative, thereby enhancing HIV research and its impacts and applications in clinical care and public health more broadly.